Core L: Behavioral Science

Abstract
Advances in HIV prevention and treatment such as PrEP, medical male circumcision, and more potent
antiretroviral therapies may be primarily biomedical in nature, but they require substantial behavioral
considerations for optimal uptake. Moreover, the 2015 White House National HIV/AIDS Strategy specifically
identifies screening and treatment of mental health and substance use disorders as critical to reducing
disparities, reducing morbidity and mortality associated with HIV, and preventing new HIV infections. Both
domestically and globally, mental health has been closely tied to substance use disorders, which impact
adherence and retention in care. A combination of behavioral and biomedical expertise, therefore, is required
to successfully address the HIV epidemic worldwide, with NIH funding priorities reflecting this need. Emanating
from the former Sociobehavioral Prevention Research Core, this newly re-imagined Behavioral Science Core
(BSC) consists of diverse, multidisciplinary faculty with relevant expertise in behavioral science who will
provide CFAR investigators with critical expertise not currently available locally. The overall goal of the BSC is
to catalyze behavioral science research that will contribute to curbing the global HIV epidemic and improve
outcomes along the continuum of HIV prevention and care. Specific aims are: 1: Promote and support
collaborative, interdisciplinary HIV research that integrates cutting-edge behavioral science by
constructing a behavioral science infrastructure within the CFAR that will maintain an online database of
CFAR behavioral resources and investigators, organize symposia to promote local and regional cross-
disciplinary collaboration, and facilitate coordinated and collaborative responses to relevant funding
opportunities; 2: Provide technical assistance related to behavioral science to the diverse community of
CFAR investigators, with a particular focus on the development and evaluation of intervention strategies,
behavioral theory, and measurement of mental health and substance use; 3: Provide training and
assistance in the use of qualitative methods, especially to inform the development and evaluation of
behavioral interventions, including a workshop series and a mobile Qualitative Methods Laboratory fully
equipped with video- and audio-recording capability for use by CFAR investigators for usability testing,
acceptability assessment, cognitive interviewing, focus group sessions, and in-depth qualitative interviews; 4:
Provide mentorship, education, and training on behavioral science integration to early- and mid-stage
investigators, with a priority on underrepresented racial/ethnic minorities by convening a monthly Junior
Investigator Group as well as (in collaboration with Developmental Core) offering consultations for relevant
New Investigator Award (NIA) applicants, participating in mock peer reviews, and supporting eligible faculty in
applying for training awards and mentoring successfully.